Village-Integrated Eye Worker trial II (VIEW II)

PROJECT SUMMARY/ABSTRACT
The World Health Organization estimates that 80% of blindness worldwide is avoidable, yet cases are
not detected early enough to prevent vision loss. To address this global burden, eye care systems must
determine optimal methods for identifying people with or at risk for visual impairment. Worldwide, systems
utilize a variety of community-based approaches to identify such cases, including screening for early disease
with telemedicine and case detection of prevalent disease with cataract camps or community health workers.
Each of these models requires varying levels of resources and ophthalmic skill, but no studies have been
conducted on the comparative effectiveness or cost effectiveness of these different approaches.
The overall objective of this project is to determine the effectiveness of community-based approaches
to prevent blindness through a cluster-randomized trial. Communities in Nepal will be randomized to one of five
arms (1) a state-of-the-art mobile screening unit employing telemedicine for screening and case detection, (2)
a mobile case detection unit focused on cataract and refractive error only, (3) a cataract camp employing
ophthalmic personnel, (4) a volunteer community health worker (CHW) program, and (5) no intervention.
Intervention arms (arms 1-4) will target all adults aged ≥50 years residing in intervention communities for
screening and/or case detection. Those meeting referral criteria will be referred to Bharatpur Eye Hospital for a
confirmatory diagnosis and follow-up care as needed, and will be closely monitored by study staff. Four years
after implementation, a population-based census will be conducted in all study communities, and eligible adults
will undergo a visual acuity assessment. To examine effectiveness and cost-effectiveness of these
approaches, we will pursue three specific aims: 1) to determine whether screening is effective for reducing
visual impairment relative to case detection (arm 1 vs 2); 2) to determine whether a CHW program increases
the rate of cataract surgery compared to cataract camp (arm 3 vs 4); and 3) to compare the costs per line of
visual impairment prevented between competing outreach programs (arms 1-5). The approach is innovative in
its use of recently developed portable diagnostic technology that enables mobile, telemedicine-based
screening on this large scale. In addition, the post-test only population-based assessment of visual acuity in a
large trial design allows for the study of a rare event like blindness and eliminates the problem of loss to follow-
up that affected previous screening trials. This research is significant because it will provide the strongest type
of evidence to guide national eye health programs – results from a randomized controlled trial. Ultimately, this
trial will benefit blindness prevention programs worldwide in deciding how to allocate limited resources to
screening or case detection.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it will determine the comparative effectiveness and cost-effectiveness of the most common community-based approaches to blindness prevention. More generally, prevention of blindness on a population level has the potential to increase economic contributions of those of productive working age at risk for blindness, improve quality of life, and reduce direct and indirect health care costs associated with ocular disease. The proposed trial is thus aligned with the National Eye Institute’s core strategy of decreasing visual impairment in populations through research on prevention.